Olfactory Mechanisms Supporting Attraction to e-Cigarette Odors

PROJECT SUMMARY
Sensory information from the environment guides behavior. In particular, odors are integral to finding food,
identifying danger, and orchestrating social behaviors. Furthermore, odors can become salient cues when paired
with reinforcers which may subsequently trigger cravings (e.g., compulsive eating, drug seeking, etc). Adolescent
use of nicotine containing electronic cigarettes (e-cigarettes) has skyrocketed in recent years. Along with
nicotine, e-cigarettes often contain appealing additives, such as fruit smells, which based upon their hedonics
promote the acquisition and maintenance of e-cigarette/nicotine use in humans and rodents. Therefore, the
odors emitted from e-cigarettes are of particular importance to their sensory perception. However, the brain
systems responsible for mediating attraction to e-cigarette odors are unknown. The tubular striatum (TuS, also
known as the olfactory tubercle) is an olfactory region that also receives modulatory input from midbrain
dopaminergic (DA) neurons to inform decision-making. The TuS' distinct connectivity and dual roles in reward
and sensory processing uniquely position it to mediate attraction to e-cigarette odors. The proposed F31 NRSA
will use respiratory monitoring, behavior, site-specific pharmacology, optogenetics, and in vivo electrophysiology
to test the hypothesis that dopaminergic systems of the TuS mediate attraction to e-cigarette odors in adolescent
mice of both sexes. In Aim 1, I will test the hypothesis that DA's actions in the TuS are responsible for e-cigarette
odor attraction. In Aim 2, I will test the hypothesis that TuS neurons expressing DA 1 receptors represent e-
cigarette odors, and that their respiratory-coupled activity encodes the difference between e-cigarette odors
containing strawberry additive (attractive) versus those without (unattractive). This project will reveal olfactory
contributions to e-cigarette use and further, will uncover fundamental insights into brain systems involved in
mediating odor attraction.

Public health relevance
PROJECT NARRATIVE The results of this proposal will enhance our understanding of how odor information is processed in the brain to ultimately influence behavior. Furthermore, this work will investigate how dopamine, a potent neuromodulator, influences attraction to odors in the context of electronic cigarettes. This proposal is therefore relevant to the missions of the NIDCD by investigating the modulation of central olfaction, odor-guided behavior, and ways these are shaped by motivational factors.